NIH Gonzalez-Amoretti Characterizing PopulationDynamics of Prefrontal Cortex which Govern the Modulation of Visual Processing

Project Summary/Abstract
The prefrontal cortex (PFC) is widely reported to play a role in visual attention, employed through modulation
of neuronal activity in visual processing regions, such as V4 and MT. Sub-regions within the PFC of monkeys,
such as the frontal eye fields (FEF) and the ventral prearcuate region (VPA), are reported to govern spatial and
feature-based attentional modulation of visual responses, respectively. However, the cellular-level circuitry and
neurocomputational mechanisms involved in the modulatory control of visual processing remain unclear.
Previous work suggests that interactions between diverse sub-populations in both FEF and VPA may facilitate
modulation of visual processing signals as well as shifts of attention, but this remains untested. The purpose
of my project is to determine the neuronal dynamics within sub-regions in PFC that govern top-
down modulation of visual processing. It is possible, that FEF may integrate signals representing object
identity which arise in VPA and transforms them to signals representing spatial locations of a target stimulus.
We plan on addressing this hypothesis by: (1) characterizing the spatial- and feature-tuning properties of FEF
in the context of visual search to understand how integration and transformation of attentional signals may be
implemented; (2) establishing the temporal dynamics between FEF and VPA to reveal the nature of neuronal
communication between both regions during visual search; and (3) determine the causal role of VPA towards
feature-based attentional modulation of visual processing via reversible pharmacologic inactivation. Monkeys
are trained on a visual search task designed to conditionally engage attentional processes that are dependent on
feature or spatial information. Using neurophysiology and population analyses, we will determine the neuronal
correlates of PFC which govern the computational processes needed to accomplish these tasks. These findings
will provide a description of the circuit-level mechanisms involved in top-down attention which often times is
affected in neuropsychological disorders and neurodegenerative diseases. Thus, this project aims to contribute
knowledge concerning the neuronal correlates of visual processing that are involved in related underlying
symptoms. Additionally, learning about how higher-level brain regions modulate visual processing may provide
more information about how perception is conjured in the brain. My environment at UR fosters the opportunity
to broaden my research skillset which ultimately facilitates my endeavor towards my career goal as a scientific
leader pushing to improve our approach of intervening with mental illnesses. The social environment at UR
provides great opportunity for outreach, allowing me to fulfill my aspirations as a community leader looking to
pave a way for underrepresented individuals which get overlooked given their backgrounds.

Public health relevance
Project Narrative Attentional deficits are present in patients suffering from neurodegenerative diseases and neuropsychological disorders. In fact, these attentional deficits manifest prior to the cardinal symptoms of such conditions, such as dementia, traumatic brain injury, and schizophrenia (Sharma et al., 2016). Thus, developing a framework for studying the systematic underpinning of cognitive processes, such as attention, may serve to improve the detection of cognitive markers for preclinical diagnostics of these neurological conditions (Levy et al., 2016).